Effect of Powassan virus genetic variation on replication in human cell culture and transmission by ticks

PROJECT SUMMARY
Powassan virus (POWV) is a neuroinvasive tick-borne flavivirus that is maintained in nature by Ixodid ticks.
Over the past decade, the number of human cases has quadrupled, and wildlife studies suggest that the
intensity of enzootic transmission is also increasing. POWV is marked by diverse transmission cycles and
disease outcomes. The virus consists of two distinct phylogenetic clades, and evidence of infection has been
observed in several tick and vertebrate species. Experimental studies of the relationships between POWV
genetic diversity, tick transmission, and disease outcome are currently lacking. The goal of this study is to
determine phenotypic diversity of POWV in vitro, identify relevant genotypes of potential medical importance,
and determine efficiency of virus dissemination in ticks. To facilitate this study, we have collected 47
environmental isolates spanning a wide geographic range in North America, from a number of tick and
vertebrate sources, and spanning over 6 decades. We hypothesize that POWV is a phenotypically diverse
virus that can differ in disease potential and ability to transmit. To test this hypothesis, we determine replication
and cytopathic effect phenotypes in human and tick cell culture. In collaboration with the Broad Institute, we
use POWV whole genome sequences to identify genetic variants that correlate with virus phenotype in cell
culture. In our second aim, we use an innovative method of barcoding virus to investigate virus dissemination
in 4 tick transmission routes: oral, vertical, transstadial, and co-feeding. This information is critical to
understanding how POWV persists in the tick vector. The results of this proposed study contribute to our
currently lacking knowledge of this emerging flavivirus. The following aims are proposed:
Aim 1: Quantify POWV phenotypic diversity in cell culture and identify genetic variants of interest.
Aim 2: Assess the effects of transmission route on Powassan virus population in Ixodes scapularis ticks.

Public health relevance
Project Narrative Understanding the phenotypic diversity of Powassan virus is essential to understanding severe POWV disease derived in humans and the upward trend of cases in the past two decades. Furthermore, characterizing the horizontal and vertical transmission routes through which POWV is transmitted through will contribute to our understanding of how this virus is perpetuated in nature, and inform models of tick-borne disease in the United States.